A Research Resource for Ultra-sensitive High Throughput Proteomics - Administration and Management

Project Summary – Administrative and Management
The role of the administrative and management component of the Proteomics Resource will be to provide and
maintain an effective management structure for the Resource, and support the combined and coordinated
Technology Research & Development (TR&D) Projects, Driving Biomedical Projects (DBPs) and Community
Engagement (CE) efforts. The Aims of the administration and management include efforts to: 1) organize and
maintain a well-integrated multidisciplinary team through well specified staff responsibilities and tasks,
2) organize and implement Resource operating procedures, and 3) ensure proper oversight of Resource
activities. Oversight activities primarily include organizing and managing both the internal and external
advisory committees and related meetings, which support managing the review and selection of collaborative
projects, overall Resource progress, and the prioritization and coordination of CE and TR&D Aims and
activities. Success will be achieved by maintaining and facilitating communications and interactions across
Resource Staff, Committee members, collaborators, NIGMS program staff, and other relevant participants as
needed.